Determining the role of AR transcriptional function in SBMA

Many neurodegenerative diseases, including Alzheimer's disease, Parkinson's disease and the
polyglutamine diseases, result from protein misfolding and accumulation due to a variety of genetic and/or
environmental causes. Spinal and bulbar muscular atrophy (SBMA) is an adult-onset, inherited
neuromuscular disease that is caused by polyglutamine expansion within the androgen receptor (AR); it is
related to other neurodegenerative diseases caused by polyglutamine expansion, including Huntington's
disease and several spinocerebellar ataxias. Although the precise pathway leading to neuronal
dysfunction and death is unknown, the evaluation of transgenic mouse and cell models of these diseases
has yielded mechanistic insights to disease pathogenesis. SBMA stands apart from other polyglutamine
diseases in that its onset and progression are dependent on AR androgenic ligands. Our cell and mouse
models of SBMA reproduce the androgen- and polyglutamine-dependent nuclear AR aggregation seen in
patients, as well as its consequent toxicity, making these models highly useful for the analysis of the
mechanistic basis for upstream events involved in AR toxicity. Previous studies from our group and others
revealed that the nuclear localization, N/C interaction, phosphorylation and acetylation of the AR are all
required for its aggregation and toxicity. Inhibiting each of these steps through genetic or pharmacological
manipulation prevents mutant AR aggregation as well as its toxicity. Notably, inhibition of each of these steps
also prevents AR transcriptional activity, highlighting a central question in the understanding of SBMA
pathogenesis of the role of AR transcriptional activity in disease. While earlier studies in a Drosophila
model of SBMA supported such a role, studies in mammalian systems suggest otherwise. Answering this
important question is critical to the development of effective therapies. We propose with this application to
answer this central question of the role of AR transcriptional activity in SBMA, through the use of novel cell
and animal models, and to use these models to investigate the molecular pathways that mediate disease.
We predict that our proposed studies will reveal further details about the role of AR transcriptional activity in
disease pathogenesis and provide robust insights into ideal therapeutic directions in SBMA. To achieve
these goals, we propose three specific aims: 1) To determine the role of AR DNA binding in disease, in
vivo, using novel, genetic knock-in mouse models of SBMA; 2) To evaluate the role of DNA binding in cell
models of SBMA; and 3) To use these models to identify common pathogenic pathways through
transcriptional profiling and quantitative analysis of mutant AR-interacting proteins. We anticipate that
results from these studies will lead us to a new understanding of the molecular pathogenesis of SBMA
and enhance our development of new therapies for SBMA.

Public health relevance
Spinal and bulbar muscular atrophy (SBMA) is one of 9 polyglutamine diseases, which are themselves part of a large family of neurodegenerative diseases characterized by protein misfolding and accumulation; these diseases also include Alzheimer’s disease, Huntington’s disease, Parkinson’s disease and amyotrophic lateral sclerosis (ALS). We have identified several proximate events in mutant AR metabolism that are involved in its toxicity. The studies proposed here will determine the role and mechanistic basis for the native transcriptional function of AR in SBMA, through the determination of the specific role of DNA binding, and in so doing, will open important and powerful opportunities for therapeutic development.